Training Program in Lung Biology and Pathobiology

Project Summary
This T32 renewal application, with demonstrated excellence in creating meritorious and next-
generation predoctoral and postdoctoral trainees in lung research, requests continued support for
the Lung Biology and Pathobiology Training Program (TPLBP) at the University of Illinois College
of Medicine, Chicago, for years 32–36. Our steadfast goal remains to train the next generation of
high-caliber trainees specializing in lung biology and the pathobiology of lung disease and its
relentless impact on patient survival worldwide. The program fosters career growth by enhancing
critical thinking and problem-solving skills and developing the resilience and determination to
succeed in research-focused professions. Each trainee will receive funding for two years. To this
end, in addition to our existing cohort of accomplished mentors, we have included newly NIH-funded
faculty mentors to reinvigorate our program. The trainees have the opportunity to engage with a
diverse group of 40 faculty members who specialize in five interconnected research areas: 1) Lung
Vascular Homeostasis, Pathobiology, and Regeneration; 2) Cellular, Humoral, and Mechanical
Bases of Lung Injury and Repair; 3) Microbiome and Metabolism in Lung Biology and
Pathobiology; 4) Lung Genomics and Data Science in Inflamed and Regenerated Vessels;
and 5) Therapeutics Targeting Lung Vessel Regeneration. In this renewal, the program has placed
our trainee’s interests above faculty research interests, and we call this approach "trainee-centric."
Our program involves mentoring through a primary preceptor, engaging in co-mentorship overseen
by several committees, including executive, external, and trainee advisory committees, crafting
individual development plans, and emphasizing communication and presentation skills. We have
also added a "feedback loop" workshop to benefit our trainees. Additionally, the program prioritizes
diversity, equity, and inclusivity, emphasizing women's roles and strong recruitment and retention
efforts. The program is highly multidisciplinary, as we have added expertise in computational biology,
data science, bioinformatics, stem cells, epigenetics, and physician science. We are requesting 5
predoctoral and 3 postdoctoral trainee positions. In the last 10 years, 75% of our trainees, including
underrepresented minorities, have engaged in academic research, and 40% received F31, AHA, or
KO9, R21, and RO1 grants. With recent advances and expanded thematic areas, we are
repositioned and re-empowered to train a select group of individuals in lung-related research. This
training will allow them to intersect with other disciplines, enhancing their careers in academia,
research institutes, the biopharmaceutical industry, and other emerging fields.

Public health relevance
Narrative This training grant application seeks support for 5 predoctoral and 3 postdoctoral trainees. These individuals will undergo training provided by well-positioned multi-disciplinary faculty in the rapidly evolving and increasingly competitive field of lung biology and pathobiology. The 5 thematic areas of research training include (1) Lung Vascular Homeostasis, Pathobiology, and Regeneration; (2) Cellular, Humoral, and Mechanical Bases of Lung Injury and Repair; (3) Microbiome and Metabolism in Lung Biology and Pathobiology; (4) Lung Genomics and Data Science in Inflamed and Regenerated Vessels, and (5) Therapeutics Targeting Lung Vessel Regeneration. The goal is to cultivate highly qualified groups of young scientists capable of developing their careers in academic research and alternative pathways.